The complement system in ALS

Increasing evidence suggests that neuroinflammation in both the central nervous system and periphery
contributes to pathophysiology and disease progression of ALS. In addition, both preclinical and clinical studies
implicate a role for the complement system in the neuroinflammatory response observed in ALS, although
mechanistic details are lacking. The overall goal of this proposal is to investigate the role of complement in the
progression and pathophysiology of disease in ALS mouse models using a novel approach of complement
inhibition. Complement inhibition will be evaluated for therapeutic potential, while at the same time used as an
investigative tool to better understand the role of complement in ALS. Although clinical trials using complement
inhibitors to treat ALS have recently been announced, the approach we will investigate offers significant potential
advantages over the inhibitors entering clinical trials. The specific aims are to examine the role of complement
and the effect of targeted C3 inhibition on disease progression and survival, and to determine complement-
dependent pathophysiology and inflammatory/immune profiles during disease progression. It is expected that
data generated will provide the foundation on which to build more detailed mechanistic investigations, as well
develop novel complement-inhibitory therapeutic approaches that could be addressed in a Merit application.
There is no effective treatment for ALS, and our therapeutic strategy has the potential to be beneficial at multiple
levels by directly protecting motor neurons from complement activation in the CNS, by protecting motor end-
plates, and by potentially modifying glia-motor neuron interactions.

Public health relevance
There is strong evidence that inflammation plays an important role in the progression of disease in amyotrophic lateral sclerosis, and the case rate for this disease is higher among deployed Veterans. Studies proposed investigate inflammatory pathways involved in deteriorating motor functions, and additionally investigates a novel therapeutic approach that targets these inflammatory pathways.